ASSESSMENT OF NUTRITIONAL STATUS &BODY COMPOSITION IN SURVIVORS OF HANTAVIRUS

This study plans to follow body composition by serial measurements once yearly for five years, including body height, weight, and skin fold estimates of percentage of body fat. Evaluate body protein stores by measurements of total protein and albumin. Assess lipid status by measurements of cholesterol and triglycerides. Evaluate caloric intake and expenditure using diet recall and exercise patterns recall.